Nuclear moonlighting of arsenic metabolic enzymes and reprogramming-resistant epimutations

PROJECT SUMMARY
The overarching goal of the research presented in this application is to understand how environmental
chemicals trigger a deregulation of the epigenome that can resist epigenetic reprogramming in germ cells and
therefore can become heritable.
Inorganic arsenic (iAs) is a model epigenetic toxicant owing to its well described impact on global DNA
hypomethylation coinciding with a reduction in the levels of the universal methyl donor SAM, used towards DNA
and histone methylation. iAs is also a chemical with well-established transgenerational epigenetic inheritance
effects, producing heritable reproductive and metabolic dysfunctions and neurobehavioral outcomes for multiple
generations. However, iAs shows remarkable complexity in its epigenetic impact since even in the context of
global DNA hypomethylation, some loci show hypermethylation and the effect on histone methylation are non-
uniform with many methylated histone marks showing increases while others show a decrease. It is unclear how
iAs causes such varied epigenetic effect and how these effects are maintained during reprogramming.
Here, we propose to leverage a unique model of germ cell reprogramming based on the step-wise
differentiation of mouse Embryonic Stem Cells (ESCs) into Primordial Germ Cell-Like Cells (PGCLCs). PGCLCs
undergo epigenetic reprogramming in vitro and are transcriptionally and functionally similar to in vivo PGCs since
they generate viable offspring upon transplantation in vivo. We will build on compelling preliminary data showing
that in mESCs, at levels where sodium arsenite does not cause a significant increase in ROS levels, a
pronounced metabolic impact on the methionine cycle and on the transsulfuration pathways are observed
concomitant with its epigenetic impact. We also show that two enzymes crucial for the one-carbon and iAs
metabolism, MAT2A and AS3MT, respectively, are strongly upregulated in response to iAs and translocate to
the nucleus where they associate with chromatin. Finally, we show that PGCLCs retain a transcriptional memory
of prior exposure to arsenic. Thus, we hypothesize that the metabolic rewiring caused by iAs exposure
causes the differential nuclear activity of reprogramming-resistant metabolic enzymes which locally
modulate the availability of SAM for epigenetic modifications.
To test this hypothesis, we will (1) assess the developmental reprogramming of iAs-induced epimutations
by WGBS, CUT&Tag, ChIP-seq, RNA-seq, and Pandora-seq in PGCLC; (2) test whether iAs metabolic impact
is required for the induction of these epimutations; and (3) examine whether iAs epimutations require the
activity of MAT2A and AS3MT at locus-specific levels.
At the completion of these aims, we will have determined how the metabolo-epigenetic crosstalks mediate
locus-specific epigenetic alterations in response to arsenic and how these epimutations resist developmental
reprogramming.

Public health relevance
PROJECT NARRATIVE The epigenome is remarkably responsive to environmental cues and is a central player in the transcriptional and physiological response to environmental exposures. However, how environmental chemicals trigger a deregulation of the epigenome that is maintained over the course of development is still poorly understood. Our research program will seek to transform our understanding of the mechanism of action of environmental chemicals by examining the role of metabolic enzymes in directing reprogramming-resistant epimutations.